Administrative Core

ADMINISTRATIVE CORE A
Co-leaders: D. Branch Moody (Brigham and Women's Hospital) and Kyu Rhee (Weill Cornell Medicine)
ABSTRACT
The Administrative Core A is led by D. Branch Moody (contact Principal Investigator) and Kyu Rhee (co-
Principal Investigator), who have broad prior administrative experience in managing multi-disciplinary
collaborative projects. The Core leaders will communicate with NIH program officers, the External Scientific
Advisory Group, the Core Administrator and the Data Manager to meet administrative, financial and scientific
goals of the tuberculosis research unit (TBRU). Core A will coordinate and monitor scientific progress toward
defined milestones, while encouraging interdisciplinary collaboration within the TBRU and among TBRU
groups that form the TBRU Network. To accomplish this goal, Core A will implement a program of scientific
communication that involves yearly national meetings at the NIH, monthly TBRU-wide scientific meetings, as
well as weekly administrative and affinity group meetings. The Data Manager will implement the data
management plan, tracking large scale metabolomics, lipidomics and genetics datasets, and coordinating data
submissions and interaction with NIAID-supported Bioinformatics Centers. The experienced Administrative
Core Associate will be responsible for the daily administration and fiscal management of the proposed TBRU,
including monitoring of subcontracts and expenditures, and managing annual reporting requirements. Core
leaders will support scientific training through individual development plans for trainees and internal programs
to support the development of non-tenured investigators working in the tuberculosis field, including a
collaborative projects program and an internship program for on-site cross-training in new techniques available
through the TBRU. Core A has an Administrative Plan that guides interactions among members of the TBRU
and provides specific timelines for scientific progress and outline processes to resolve problems.